Support for the NIH Database for Combating Antibiotic Resistance Bacteria

To support the NIH National Center for Biotechnology Information to maintain a national database of genomic and other data sources on resistant bacteria as outlined in the National Action Plan to Combat Antibiotic Resistant Bacteria. This effort addresses the growing problem of antimicrobial resistance.